Dissecting Yersinia Yop Targets in Neutrophils

ABSTRACT
Neutrophils (PMNs, polymorphonuclear cells) are pivotal innate immune cells that directly mediate
pathogen clearance through release of reactive oxygen species (ROS), degranulation, neutrophilic
extracellular traps (NETs) and phagocytosis. The bacterial pathogen, Yersinia pseudotuberculosis (Yptb)
antagonizes these antimicrobial actions by injecting critical virulence proteins, called Yops, into PMNs. We
seek to understand mechanisms that mediate clearance of bacterial pathogens in tissue infection by
understanding the processes that are disrupted by YopH and YopO. We have shown that SKAP2 is one
essential target of YopH in PMNs in tissue infection; however, SKAP2 is not the only essential target of YopH
in tissue infection. Missense mutations in SKAP2 are associated with the development of autoimmune
disorders and cancers. This suggests that PMN dysfunction downstream of SKAP2 signaling has wide ranging
implications beyond infection control. We have further shown that SKAP2-dependent mechanisms in
neutrophils are critical for limiting growth of another Gram-negative pathogen, Klebsiella pneumoniae (Kp), in
lungs. Using PMNs derived from myeloid progenitor (MP) hematopoietic stem cells, we found that SKAP2 is
essential for extracellular (ROS) production but is not required for degranulation after Kp infection. Surprisingly,
SKAP2 is required for Syk phosphorylation after infection by Kp, but not for Syk phosphorylation after
stimulation of CLRs and integrin receptors, indicating that neutrophil recognition of Kp is via a distinct receptor,
possibly a G protein coupled receptor (GPCR). The objective of this application is to use our expertise in
murine infection models, MP-PMN genetic manipulation, bacterial genetics and live-cell visualization of protein
complexes, to understand pathways in PMNs that are targeted by YopH and YopO. We will further investigate
whether these targets play crucial roles in the control Kp. To this end, our specific aims are to (1) Dissect the
modular functions of SKAP2 required for generating anti-microbial responses in neutrophils after infection with
Kp. (2) Understand the effects of YopO on GPCR signaling in PMNs during murine infection. (3) Identify the
SKAP2-independent pathways that are targeted by YopH to inactivate neutrophil degranulation. After
completion of these studies, we will understand how SKAP2 and other Yop-targeted proteins work in PMNs to
control infection by Kp and Yptb. A thorough understanding of molecular mechanisms that signal for the
release of the tissue damaging bactericidal factors, ROS and granules, by PMNs during infection should lead
to novel and targeted approaches to manipulate these pathways to enhance these activities during infection
with multidrug resistant bacteria and to stop excessive damage due to uncontrolled PMN responses in a
variety of auto-immune diseases.

Public health relevance
Project Narrative We seek to understand the contributions of distinct antimicrobial functions in neutrophils that are targeted by YopH and YopO from the bacterial pathogen, Yersinia pseudotuberculosis and then assess whether these functions are critical to control growth of Klebsiella pneumonia, during lung infections.